STUDIES ON THROMBIN ALLOSTERY

Our laboratory has discovered the Na+-dependent allosteric enhancement of catalytic activity in thrombin and related serine proteases involved in blood coagulation and the complement system, identified the Na+ binding site and elucidated the importance of Na+ binding in the function and evolution of serine proteases. The proposed research project is aimed at gaining a complete functional and structural characterization of thrombin allostery and how it influences recognition of physiological substrates, effectors and inhibitors. We will use a combination of kinetic, mutational and structural studies to identify regions of the enzyme that are under the influence of Na+ binding and constitute the structural scaffold through which the Na+ site communicates changes of functional significance to binding epitopes for physiological ligands. We will determine what regions of the enzyme are involved in recognition of fibrinogen, protein C, the thrombin receptor PAR1, thrombomodulin, heparin and anti- thrombin III with unprecedented detail. The new information to emerged from the proposed studies will broaden our understanding of thrombin interactions in the blood and will enable the identification of molecular targets for new anti-coagulants. We will also exploit the knowledge gained on thrombin allostery to introduce Na+ binding and enhanced catalytic activity in the fibrinolytic enzyme tissue plasminogen activator. These mutational studies will produce more proficient derivatives of the enzyme that may benefit the current treatment of acute myocardial infarction and stroke. Developments from the proposed research plan will impact on the treatment and prevention of thrombotic disorders in which thrombin is directly involved, will have a broad impact on the study of allosteric proteins in general and will demonstrate that proteases with enhanced catalytic activity can be engineered rationally to benefit areas of medical and biotechnological importance.